IV-Regulation of spinal musculoskeletal interactions

PROJECT SUMMARY (See instructions); Throughout life, the nervous system acquires and maintains many different motor skills. These skills rely on the spinal circuits that determine the interactions between the spinal cord, which excites the muscles, and the peripheral apparatus that produces movements and provides sensory feedback. It is now clear that the brain continually adjusts these circuits to support new skills, to maintain older skills, and to reduce the functional impact of aging, trauma, and disease. The goal of this project is to advance understanding of how the brain exerts the long-term control over these circuits that keeps the spinal cord and the periphery working together effectively, and to apply that understanding to develop new therapeutic methods. Animals and humans can gradually change the spinal stretch reflex (SSR) or its electrical analog, the Hreflex, in response to an operant conditioning protocol. These reflex changes are simple motor skills (i.e.,

Public health relevance
RELEVANCE (See instructions): This work should help to explain how brain and spinal cord work together to maintain effective spinal musculoskeletal interactions. They should also guide development of new methods for restoring effective interactions and thereby improving function after trauma or disease. Reflex conditioning protocols could target the specific deficits of each individual, and might thereby complement existing rehabilitation methods.